Impaired methylation alters lipid droplet dynamics in liver and adipose tissue: Role in hepatic steatosis

The development of fatty liver (steatosis) is an early manifestation of alcoholic liver disease (ALD) that can
progress to alcoholic hepatitis and cirrhosis with continued alcohol misuse. Hepatic steatosis is a benign and
reversible early stage of ALD. However, fat accumulation is regarded as the “first hit” that leaves the liver more
vulnerable to multiple hits leading to ALD progression, and is therefore, a prime target for therapeutic
intervention. Our long-term objective is to (i) understand the mechanisms of alcoholic steatosis development
and (ii) formulate strategies for treatment/prevention of this and other fatty liver diseases that present with
similar histopathological and disease progression characteristics such as non-alcoholic fatty liver disease.
We have shown that alcohol-impaired activity of a major liver enzyme, phosphatidylethanolamine
methyltransferase (PEMT), inhibits very-low-density lipoprotein (VLDL) secretion, contributing to the
development of hepatic steatosis. PEMT catalyzes the methylation of phosphatidylethanolamine (PE) to
generate phosphatidylcholine (PC), which is preferentially used in the assembly of VLDL and is necessary for
its normal secretion. We have further shown that treatment with betaine, (a methyl donor) increases PC
generation by normalizing PEMT activity. This, in turn, normalizes VLDL secretion rate and thus prevents
alcoholic steatosis.
It has been demonstrated that hepatic cytoplasmic lipid droplets (LDs) play an integral role in VLDL
biogenesis. This is because VLDL assembly is regulated by the availability of triglycerides stored in these LDs
which must be hydrolyzed to provide substrates for VLDL biogenesis. LDs are surrounded by a monolayer of
phospholipids; PC is the most abundant class followed by PE. Further, an orbit of proteins determines the
metabolic fate of LD lipid stores. Reduction in LD monolayer PC:PE ratio promotes fusion of these organelles
to form supersized structures that are more resistant to lipolysis. Furthermore, a lower PC:PE ratio enhances
the binding of the LD-associated proteins known to protect this organelle from lipase digestion. We have
evidence that phospholipid and protein composition of hepatic LD changes with the initiation of alcohol-induced
hepatic steatosis. Importantly, ethanol-induced hepatic LD accumulation occurs in conjunction with impaired
VLDL production and enhanced adipose lipolysis-generated free fatty acid delivery and uptake. However, little
is known about why alcohol promotes LD accumulation in hepatocytes but enhances adipocyte LD shrinkage.
Based on these considerations, we present a novel hypothesis that alcohol impaired methylation contributes to
the development of hepatic steatosis by inhibiting liver LD lipolysis and promoting adipose LD breakdown. We
propose that liver phospholipid methylation defect lowers the LD monolayer PC:PE ratio to generate enlarged
structures with altered composition of LD-associated proteins. These changes together hinder the lipolysis of
the hepatic LD triglyceride stores to disrupt VLDL biogenesis resulting in fat accumulation. Conversely, adipose
methylation defects activate lipases that promote LD lipolysis and fatty acid export. We further postulate that
betaine supplementation reverses alcoholic steatosis by normalizing hepatic LD monolayer PC:PE ratio and
VLDL biogenesis, and by regulating adipose LD lipolysis, hepatic fatty acid uptake and metabolism.
To test our hypothesis, we propose the following Specific Aims:
Specific Aim 1: To characterize how ethanol alters the phospholipid and protein composition of LDs.
Specific Aim 2: To examine the effect of alcohol on LD lipolysis for mobilizing triglyceride stores.
Specific Aim 3: To determine the effect of betaine on alcohol-induced alterations in LD dynamics.
Completion of these studies will provide insight into the importance of maintaining essential methylation
reactions in regulating the dynamics of hepatic and adipose LDs and preventing the development of alcoholic
steatosis and other chronic liver diseases including non-alcoholic fatty liver disease.

Public health relevance
Chronic alcoholism and alcoholic liver disease (ALD) are common factors associated with the hospitalization of our Veterans. The earliest manifestation of ALD is the development of hepatic steatosis that is characterized by accumulation of fat in the hepatocytes. Although, often benign and reversible, hepatic steatosis is widely believed to being the precursor to fibrosis, cirrhosis and cancer and therefore is a prime target for therapeutic intervention. Our objectives are to (i) understand the mechanisms of alcoholic steatosis development and (ii) develop therapeutic intervention of using a methyl donor, betaine, to manage and treat alcoholic and other fatty liver diseases that presents with similar histopathological and disease progression characteristics such as non- alcoholic fatty liver disease. Since betaine is safe, inexpensive and readily bioavailable, its large-scale use has the potential to reduce the economic burden to the VA health care system.